Evolution of Mammalian Sex Chromosome Dosage Compensation

Abstract
Mammalian dosage compensation equalizes X-linked gene expression between XX females and XY
males. Defective dosage compensation can cause cell and organismal lethality. Current models posit that
mammalian dosage compensation requires X-inactivation and that X-inactivation requires the X-linked Xist
long noncoding RNA. Despite much work, however, whether Xist and X-inactivation are essential for dosage
compensation remains unclear. The goal of this proposal is to define how mammalian dosage compensation
originated and evolved. The overall objectives of this proposal are to (i) determine the temporal and tissue-
specific requirement of Xist RNA and X-inactivation in dosage compensation; and, to (ii) test the contributions
of ancestral and evolutionarily conserved X chromosome-encoded factors in dosage compensation in the
mouse model system. The central hypothesis of the proposal is that mammalian dosage compensation
originated independently of Xist and X-inactivation and that ancestral X chromosome-encoded factors
equalized X-linked gene expression between the sexes. The rationale for this proposal is that it provides
insights into how cells manage differences in their sex chromosome complements specifically and how cells
equalize gene expression despite differences in chromosome copy number more generally. The proposal's
central hypothesis will be tested through the following approaches: 1) determine the requirements of Xist RNA
and X-inactivation in dosage compensation in the epiblast lineage, which generates all somatic tissues; and, 2)
test the contributions of two ancestral X chromosome-encoded genes in dosage compensation in the absence
Xist and X-inactivation. Dosage compensation will first be analyzed in homozygous Xist-null (XistD/D) female
mouse embryos, embryonic stem cell (ESC)-derived epiblast-like cells (EpiLCs) and neural progenitor cells
(NPCs), and tissues of XistD/D female mice, which we have found to be viable and fertile. Next, X chromosome
dosage compensation will be tested in embryos, EpiLCs, NPCs, and tissues of adult mice that lack Xist and
also one or both alleles of the candidate ancestral dosage compensation factors. The proposed research is
innovative and potentially transformative because it defines novel and Xist- and X inactivation-independent
mechanisms of mammalian dosage compensation using advanced transcriptomic and chromatin profiling
techniques. In the absence of Xist and X-inactivation, the proposal's central hypothesis predicts that the
ancestral candidate genes execute dosage compensation either through random monoallelism or by
simultaneously diminishing expression from both alleles of X-linked genes in XX female cells. The significance
of the proposal is that it will define when, where, and which genes Xist RNA silences during development and
delineate the functions of ancestral X-linked genes in novel Xist- and X inactivation-independent modes of
dosage compensation. Overall, the proposal promises to mechanistically define how mammalian X
chromosome dosage compensation originated and has evolved.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Narrative This proposal is relevant to public health because it seeks to understand how females with two X chromosomes and males with a single X chromosome equalize gene expression from the X chromosome. The proposed research will test the contribution of X-chromosome inactivation, which silences genes on one of the two X chromosomes in females, as well as novel evolutionarily-ancient mechanisms in equalizing X chromosomal gene expression between the sexes. The proposal is relevant to the part of the NIH mission that seeks to advance fundamental knowledge about the nature of living systems.